Administrative Core

ABSTRACT ADMINISTRATIVE CORE
The structure of the Einstein Aging Study program project (EAS P01) is efficient and highly effective as
demonstrated by our 25+ years of productivity. The Administrative Core provides the foundation for this
structure and plays a central role in fostering cohesion among the research sites, cores, projects and
investigators; coordinates all project related activities; promotes EAS growth and innovation; and ensures that
objectives are met. Drs. Carol Derby and Richard Lipton (from Einstein) and Orfeu Buxton (from the
Pennsylvania State University) will share EAS administrative and scientific leadership in the EAS P01. This
team reflects expertise pertinent to our expanded focus on ambulatory methods for assessing exposures and
cognitive performance. As in prior funding periods, the Administrative Core will be responsible for management
of study resources, managing and integrating scientific research goals of the EAS P01, serving as a liaison
with collaborators, and recruitment and follow-up of study participants. These functions are carried out in
cooperation with four established committees. The Long-Term Planning Committee establishes programmatic
priorities, and coordinates allocation of resources to meet individual and overall project goals. The Scientific/
Administrative Committee monitors subject recruitment and retention, supervises data management, reviews
scientific advances and progress at regular meetings, promotes scientific collaborations with other aging
research programs at Einstein, and oversees the sharing of data and bio-specimens with consortia and
investigators at other institutions (e.g., management of resource sharing agreements). The Fiscal Oversight
Committee oversees management of budgets and personnel, including the preparation of annual progress
reports for the National Institute on Aging and the Einstein Institutional Review Board. The Administrative Core
will rely on an External Advisory Committee to provide input regarding analytic approaches, study procedures,
and long-term strategy, and will be responsible for coordinating regular meetings with them and for
implementing their recommendations and suggestions. The Administrative Core also will foster liaisons with
community groups to enhance community relationships and study participation and provide outreach to the
scientific community.

Public health relevance
NARRATIVE The Administrative Core is responsible for coordinating administrative, scientific, and fiscal activities of the Einstein Aging Study (EAS) Program Project. The cohort is a systematic sample of our diverse Bronx Community. A major strength of this Core is its ability to facilitate efficient and effective sharing of data from the EAS through internal and external collaborations. These collaborations expand the utility of this valuable database by increasing the availability to the broader aging research community as well as to the communities represented by our participants.